SUBSTITUTE RAS FOR HERPESVIRUS SAIMIRI STP ONCOGENE IN LYMPHOCYTE TRANSFORMATION

STP-C488 (STP of herpesvirus saimiri [HVS] group C strain 488 [C488]) is the only virus-encoded protein found to associate with cellular ras and activate ras signal transduction pathways To investigate an important role for ras signal transduction in STP-dependent growth transformation, we constructed recombinant strains of HVS C488 in which the STP-C488 oncogene was replaced with cellular normal ras (c-ras) or viral oncogenic ras (v-ras) Recombinant HVS STP/v-ras immortalized primary common marmoset T lymphocytes to inter-leukin-2-independent growth as efficiently as wild-type HVS C488 (wt HVS), while recombinant HVS STP/c-ras did so with low efficiency Whereas wt HVS immortalized CD4- CD8+ single-positive T lymphocytes, HVS STP/c-ras- and HVS STP/v-ras-immortalized cells were principally CD4+ CD8+ double-positive T lymphocytes In addition, HVS STP/v-ras-immortalized T cells showed a high level of ras expression and exhibited an adherent macrophage-like morphol ogy These phenotypes were likely caused by the drastic activation of AP-1 transcriptional factor activity Finally, HVS STP/v-ras and HVS STP/c-ras each induced lymphoma in one of two common marmosets, although onset of disease was more rapid with the v-ras virus These results demonstrate that ras can substitute for the STP oncogene of HVS C488 to allow immortalized growth of primary lymphoid cells and that an activated form of ras does so more efficiently than the normal cellular form of ras PUBLICATIONS Guo, J, Williams, K, Duboise, SM, Alexander, L, Veazey, R and Jung, JU Substitution of ras for the herpesvirus saimiri STP oncogene in lymphocyte transformation J Virol 1998; 72:3698-3704